Advancing HIV Vaccine Development with a Lipid Nanodisc Platform

The envelope (Env) glycoprotein of HIV is the only viral protein on the surface of virions, making it the
sole target of B cell-based HIV vaccines. While Env is natively a transmembrane protein, most vaccine
development relies on soluble versions of the trimer. These versions lack the membrane-proximal external
region (MPER) epitope, the native bilayer environment, and the transmembrane (TM) and C-terminal (CT)
domains. Broadly neutralizing antibodies (bnAbs) targeting MPER have remarkable breadth, reaching near-
complete coverage of all circulating HIV strains, thus making MPER an attractive target for vaccine
development. Recent progress in MPER-targeted vaccine development has been notable on two fronts.
First, in the HVTN133 clinical trial, MPER peptide presented in a liposome formulation induced a B cell
lineage for bnAbs and their precursors and reached 15 % neutralization breadth of a global tier 2 panel.
Second, two studies described the development of a germline targeting immunogen for 10E8-class MPER
bnAb, and affinity maturation process of the primed antibodies in pre-clinical mouse models. While mRNA
technology can now deliver membrane-bound Env immunogens with a complete MPER, circumventing the
need to produce recombinant transmembrane Env, the characterization of new immunogen candidates and
the MPER-targeting responses they elicit will still require biophysical and structural analysis. As a result,
challenges in handling Env as a recombinant transmembrane protein persist. This project incorporates
engineered transmembrane Env vaccine candidates into stable lipid nanodiscs using membrane scaffold
proteins and a selection of lipid molecules. This solution enables scalable and reproducible in vitro
characterization and optimization of engineered transmembrane Env-based immunogens and evaluation of
in vivo responses from MPER-targeting immunizations. Env nanodiscs allow using transmembrane Envs
under identical conditions that have been established for soluble Envs in commonly used iterative vaccine
development methods. In the first specific aim of this proposal, Env nanodisc structures are solved in
complex with MPER-targeting antibodies to give guideposts for vaccine development. In the second,
nanodiscs are assembled with controlled lipid compositions to elucidate the contribution of the bilayer
surface to MPER antibody binding. Lastly, the third specific aim establishes conditions for utilizing Env
nanodiscs in electron microscopy-based polyclonal epitope mapping (EMPEM). All aims will collectively
contribute to improved nanodisc assembly pipeline that can be scaled to serve multiple HIV MPER
targeting vaccine development projects. This pipeline can also serve the development of any
transmembrane Env immunogen that targets other epitopes, and which will be administered as mRNA-
LNPs. Ultimately, the tools will be made available for other virus glycoprotein vaccine development
projects beyond HIV.

Public health relevance
mRNA-LNP formulations can now deliver vaccines that encode more native-like, transmembrane virus glycoproteins. Pre-clinical testing of these vaccine designs however rely largely on truncated versions to increase solubility and protein yields. This project establishes a scalable and reproducible lipid nanodisc platform as a tool to stabilize transmembrane HIV Env glycoprotein for common methods in vaccine development.